Core 2: Outreach & Recruitment Core

The Outreach and Recruitment Core (ORC) of this SPORE application will play an integral role in the proposed research to achieve the overarching goal of maximizing the impact of our translational research in our catchment area [Hawaiʻi and the US-Affiliated Pacific Islands (USAPIs)]. We will perform outreach and recruitment activities specifically in support of the two projects and, in the process, engage our catchment area populations broadly to increase their awareness of newly identified population differences in cancer risk and awareness and obtain their input on our research and dissemination of findings. The ORC team is highly experienced in outreach, especially in engaging local physicians and high-risk populations including Asian Americans, Native Hawaiians and Pacific Islanders (AANHPI) in Hawaiʻi and USAPI. Also, the ORC team collectively has a strong track record of recruiting research participants and administering complex study protocols over the past 30 years. In Aim 1, we will establish the SPORE's Catchment Area Advisory Board (CAAB) to increase public and healthcare provider awareness of population and geographic cancer differences among AANHPI in Hawaiʻi and elicit input, participation, and knowledge related to the SPORE research projects addressing liver, lung and breast cancers. In Aim 1 increase awareness of the SPORE's newly identified population differences in cancer risk and outcomes among healthcare providers and patient organizations, and engage their input and participation in the SPORE projects. In Aim 2, conduct provider and population-based key-informant interviews, and pilot message testing for Project 2; c) disseminate the risk assessment research and study findings to stakeholders for Project 3; and d) support the pilot work funded by the Developmental Research Program (DRP) and Career Enhancement Program (CEP). Bidirectional engagement with the catchment area populations throughout the research process is essential for translational research to be successful. The ORC, in collaboration with the SPORE PAB, will assist current and future SPORE investigators in obtaining stakeholder and population inputs into their research. The ORC will build on the extensive experience in outreach and engagement activities of our Cancer Center, the only NCI-designated cancer center in the Pacific region, and will establish the foundation for important translational research addressing cancer population differences in our catchment area and beyond as part of a P50 SPORE.